Sliding microgel-based synthetic platelets for managing traumatic bleeding

Proposal Summary/Abstract
Uncontrolled bleeding following trauma is the major cause of death in both civilian and military
settings, responsible for approximately 2 million deaths per year worldwide. Rapidly addressing
life-threatening hemorrhages at trauma scenes is crucial for reducing preventable trauma deaths,
yet it remains a significant challenge. The overall goal of this project is to develop a hemostatic
agent suitable for systemic administration to trauma patients in prehospital settings. Our approach
in designing this agent is inspired by the pivotal role of platelets in identifying bleeding sites and
arresting hemorrhage. Specifically, we propose sliding hydrogel-based microparticles as synthetic
platelets to replicate the adhesion and shape-changing behaviors of platelets. This is important
because platelets after adhering at vascular injury sites experience dramatic morphologic
changes, facilitating hemostatic plug formation and clot stabilization. However, mimicking their
dynamic morphologic changes and the underlying hemostatic functions in synthetic materials
systems has been a difficult task. We chose the sliding hydrogel because of its unique topological
structure, consisting of linear polymer chains threaded through and crosslinked by bicyclic rings.
These sliding crosslinks make the hydrogel highly deformable. We will further functionalize these
sliding rings with multiple bleeding-site-binding peptides. Our central hypothesis is that after
intravenous injection, these highly deformable sliding microgels with bleeding-site-binding
moieties accumulate at vascular injury sites and adapt morphologically to promote clot formation
and stabilization, ultimately halting traumatic bleeding. In this work, we will fabricate sliding
microgels with injury-targeting and shape-changing ability; and assess their hemostatic efficacy
in vitro and in vivo.

Public health relevance
Project Narrative There is a critical medical need for managing massive traumatic bleeding in the prehospital stage. This project focuses on developing a novel platelet-mimicking particle as a systemic hemostatic agent to stop bleeding after trauma. We expect this project will lead to new hemostatic strategies that can save lives.